TEMPORAL RELATIONSHIP BETWEEN SYNAPTIC ACTIVITY AND ABETA AGGREGATION

DESCRIPTION (provided by applicant): Accumulation of Aβ plaque in the brain is a hallmark feature of Alzheimer's disease and a biomarker of disease progression. Observations in humans show that plaques are found in regions of the brain that display high levels of neuronal activity, sometimes referred to as the default mode network. Similarly, about 10% of individuals with temporal lobe epilepsy develop plaques within affected areas as early as 30 years of age. Studies from our lab have demonstrated that direct modulation of synaptic activity dynamically regulates brain Aβ levels in awake animals, with increased synaptic activity rapidly increases brain interstitial fluid (ISF) Aβ levels and vice versa for suppressed activity. These findings strongly suggest a close temporal relationship between synaptic activity and Aβ generation. Determining the mechanisms that underlie this link remains important for understanding the pathological development of AD. We have developed novel micro- immunoelectrode electrodes (MIEs) that detect Aβ with very high temporal resolution (measures Aβ in vivo every minute). This approach enables us to study the rapid kinetics and dynamics of Aβ in vivo. In our published studies (Prabhulkar et al. 2012), and in preliminary data we show that these MIEs can specifically measure ISF Aβ1-40, Aβ1-42 or aggregates, depending on the antibody attached to the electrode surface. Our in vivo MIE studies demonstrate brain interstitial fluid (ISF) Aβ levels change from minute-to-minute in APP/PS1 transgenic mice. Previous publications from our group and others demonstrate that ISF Aβ levels are closely linked to synaptic transmission. In vitro data suggest that high concentration and low pH facilitate conversion of Aβ into toxic aggregates. Synaptic activity increases Aβ generation within endosomes, a confined location where the pH is low, and the concentration of Aβ can potentially be elevated. We propose that there is a rapid link between synaptic transmission and Aβ generation, with higher frequencies of synaptic transmission causing more Aβ to be formed. In addition, elevated synaptic Aβ generation in low-pH endosomes will convert Aβ into aggregated species (either oligomers or fibrils). The goal of this proposal is to use this new MIE technology in combination with pharmacological manipulation to block or enhance specific aspects of synaptic activity to elucidate the cellular mechanisms that regulate Aβ generation and aggregation on a short time-scale. The results of these studies will improve our understanding of the temporal relationship between synaptic activity and Aβ generation/species and uncover mechanisms involved in the progression of AD.

Public health relevance
Accumulation of Aβ peptide in the brain likely initiates disease onset and causes of many of the cognitive and behavioral symptoms related to Alzheimer's disease (AD). In humans and animal models of AD, brain regions with the highest levels of synaptic activity show the greatest amount of Aβ plaques, suggesting Aβ production is closely related to synaptic transmission. How quickly Aβ is generated following synaptic activity is currently unknown and unable to be measured using current methods. We have developed novel micro- immunoelectrodes (MIEs) that can measure brain interstitial fluid (ISF) Aβ levels every minute in living mice over time. MIEs utilize traditional amperometry to detect oxidation events (which are proportional to concentration), however anti-Aβ antibodies are coupled to the electrode surface to provide selectivity for measuring specific length and species of Aβ. We will utilize MIEs to measure very rapid changes in ISF Aβ levels in the mouse brain following both increase and decrease synaptic activity. We also propose that toxic aggregates of Aβ may form particularly in the presence of elevated synaptic activity. Using these micro- immunoelectrodes, we will uncover the fast-acting mechanisms that immediately influence Aβ generation and aggregation in the mouse brain.